Biospecimen Analysis

The Biospecimen Analysis Core (BAC) of our Vanderbilt-coordinated human Virome Characterization Center
(V2C2) is designed to enable the composition and complexity of a host-contextualized human virome (replicating
and integrated) to be rapidly and cost-effectively generated with high-quality across multiple tissue types. In Aim
1, the BAC will receive and characterize the virome across a range of biospecimen types from our Biospecimen
Collection Core (BCC). This process will include viral sequencing (whole metagenomics/metatranscriptomic
sequencing), validation studies (digital PCR and capture-based methods, among them), and host response
characterization, including tropism studies (via bulk and single-cell RNA-seq approaches, in vitro infection
studies) and assessments of host inflammatory state (targeted proteomics). In Aim 2, the BAC will establish
standard operating procedures for metadata, analytics, and quality control and assessment, including
consortium-wide benchmarking and reproducibility of critical assays to investigate and limit variability from the
collection point to the final analysis. The BAC will synergize with all other V2C2 cores via (1) scientific counsel
to the administrative core and the wider HVP on the development of new technologies based on HVP results to
enable viral screening at the epidemiologic scale; (2) enabling collaborative projects with other HVP efforts (e.g.,
tropism studies with Functional Interactions projects; RFA-RM-23-017), augmenting essential human
translational biology in the HVP. Our BCC has several fundamental strengths that ensure success, including: (1)
leadership structure with extensive expertise in large epidemiologic efforts: Dr. Simon Mallal (a renowned
physician-scientist who works on viral-host co-evolution and genetic interactions, Director of the Vanderbilt
VANTAGE sequencing core), Dr. Jane Freedman (a leader in sequencing and proteomics and large NIH studies,
including Common Fund efforts), and Dr. Suman Das (a human molecular virologist with extensive experience
in methods development and discovery in human virology), all of whom have a track-record of collaboration in
large NIH-funded human studies; (2) deep expertise in viral sequencing: Dr. Das and Mallal have sequenced
many classes of human viruses (e.g., influenza, RSV, HIV, HCV, HBV, EBV, enteroviruses, rotavirus, norovirus,
Ebola, Zika, coronaviruses, resulting in >400K Genbank accessions); (3) expertise in methods development in
metagenomics: in this process, they have developed many new laboratory and computational methods enabling
capture of the human virome (replicating eukaryotic RNA/DNA viruses and phages) and host integration; (5)
rapid assessment of host response characteristics (including mucosal immunity, relation with other
commensal microbial flora, and emerging types for characterization [e.g., extracellular vesicles, platelets,
proteomics]); (6) large, NIH-funded core laboratory structures that enable cost-efficient BAC conduct (e.g.,
NHLBI TOPMed 2.0 Core; Vanderbilt resources led PD Mallal/PI Das). Successful completion will provide HVP
with a comprehensive host-viral characterization for consortium-wide integration.